Protocol Review & Monitoring System

PROTOCOL REVIEW AND MONITORING SYSTEM – PROJECT SUMMARY/ABSTRACT
The University of Virginia Cancer Center (UVACC) conducts a robust two-stage review for rigorous internal
oversight of the scientific aspects of all cancer clinical studies.
The First stage review is via Disease Teams that are involved in trial selection, implementation, study
coordination, and data management. Each disease team consists of disease-focused clinical research
investigators (MD and PhD) and study staff involved in the development and conduct of clinical studies. Each
disease team defines their clinical research priorities. The first stage review by disease teams helps eliminate
many trials from moving forward in the start-up and implementation process.
Second stage review is via the UVACC Protocol Review and Monitoring System, which oversees and ensures
the scientific merit, priorities, and progress of all cancer clinical studies conducted at the UVACC. A Protocol
Review Committee (PRC), appointed by the UVACC Director and administratively supported by the Office for
Clinical Research, has been given the authority and charge to carry out this mandate.
The PRC is chaired by Ryan Gentzler, MD. Its primary goal is to ensure that investigator-initiated and industry-
initiated cancer research studies involving human subjects conducted at the UVACC are: (1) scientifically and
statistically sound; (2) appropriately designed; (3) feasible for completion; and (4) in compliance with NIH
guidelines for human studies.
The PRC also plays an important role in mediating competing studies by requiring adherence to an institutional
prioritization plan and patient availability, and closely monitors the clinical trial progress and rules for
termination of studies in the UVACC based upon accrual and continued scientific relevance.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.